A FAIR Bridge2AI Center (FABRIC)

Bridge2AI: a FAIR AI BRIDGE Center (FABRIC) Overall Summary
We propose to develop a FAIR Bridge2AI Center (FABRIC) to organize a large Consortium of
institutions that will be generating data and tools to enable the application of novel AI algorithms
to solve biomedical or behavioral problems affecting human health. Our center’s approach is to
develop an Administrative Core that, together with a Teaming Core, designs and manages
structural components of the Bridge2AI Consortium with a focus on team science and inclusion.
The products and activities of each of four Cores are led by experts in their respective fields, and
who have an extensive track record of working together in large NIH-funded initiatives, such as
BD2K, All of Us, etc. The Administrative and Teaming Cores are based at the University of
California San Diego. The Ethics Core, led by Vanderbilt University, will oversee all ethical, legal,
and social implications (ELSI), generate guidelines and assess fairness in data from Data
Generation Project (DGP) and other Consortium products. The Standards Core, led by University
of Texas Health, will ensure that all products and activities follow the FAIR (findable, accessible,
interoperable, reusable) principles and are harmonized/standardized to agreed upon standards.
The Tool Optimization Core, led by the Broad Institute, will use its experience developing large-
scale software to build a platform for the whole Consortium, where Cores and DGPs can have
their products available for other researchers. It will also optimize various tools that are deemed
useful for Bridge2AI. The Skills and Workforce Development will develop and deliver educational
materials and activities for the whole consortium and optimize software developed by others. A
special emphasis for FABRIC is inclusion, as our vision is for a novel type of Coordinating Center
where there is no single point of control and in which transactions (e.g., data access, data use)
are immutably recorded in an easy-to-access ledger that is viewable by all. FABRIC is designed
so that various threads in Cores and DGPs are interwoven into a durable, sustainable center for
the Bridge2AI Consortium.

Public health relevance
Bridge2AI: a FAIR AI BRIDGE Center (FABRIC) Overall Narrative We will organize the Bridge to AI Consortium by integrating the work of six major teams working on administration, team science, ethics, standards, tools and training. These teams will interact with those of data generation projects to accelerate AI research related to human health.